Mechanism of evasion of cyclic oligonucleotide-based anti-phage signaling system

Project Summary
Bacteriophages (Phages) are viruses that attack bacteria. Not only are phages valuable resources
for novel biotechnological and molecular biology tools, but they can also be used in clinical
settings for treating antibiotic-resistant infections. Bacteria carry many mechanisms to defend
against phage infection and, in turn, phages have acquired counter-defense mechanisms to
evade the protection. Many of these defense and counter-defense systems have
counterparts in the eukaryotic innate immune systems. Therefore, understanding the arms
race between the phages and their bacterial hosts is important for future development of phage
therapy and other antiviral strategies.
Here we will study how some phages evade the protection offered by a specific phage defense
system present in many bacteria including some deadly pathogens. Specifically, we have
identified a phage protein that antagonizes an antiviral system in the human pathogen Vibrio
cholerae and other important pathogens. We will determine the counter-defense mechanism of
this phage protein, and we will identify the role of this phage protein during phage infection. The
investigation proposed here will not only inform the molecular mechanism of this arms race, but
we will learn how phage-bacteria interaction shapes the evolution of a deadly pathogen. Our
findings could have significant ramifications for improving human health.

Public health relevance
Project Narrative Viruses that attack bacteria, known as phages, are valuable resources for novel biotechnological tools and they can also be used in clinical settings for treating antibiotic-resistant infections. Here we will learn how phages can effectively attack bacteria including some deadly pathogens. Our findings could have significant ramifications for improving human health.